Decoding lineage and fate specification in the C. elegans embryo

ABSTRACT
Single cell approaches to measure gene expression genome-wide across all cells of developing organisms are
beginning to revolutionize our study of development, but we are still learning how to maximize the use of single
cell “atlases” and related methods to learn new developmental mechanisms. The C. elegans embryo is an
ideal system for single cell approaches because of its invariant development and powerful experimental tools.,
and the conservation of major regulatory mechanisms with humans. We have developed large-scale
expression resources to learn the “parts list” of embryonic fate specification. These include a single-cell RNA-
seq atlas of gene expression across most embryonic cells as well as protein expression profiles of hundreds of
transcription factors in the “Expression Patterns in Caenorhabditis” (EPIC) database that contains the
expression of over 250 fluorescent reporters analyzed by automated lineage tracing and expression mapping
methods. This proposal aims to understand the zygotic regulation of lineage specification during the period
from ~gastrulation through terminal differentiation. This critical developmental period was previously hard to
study due to redundancy and complex phenotypes, but our pioneering work combining single cell approaches
with mechanistic reverse genetics is helping to overcome these hurdles. Our recent and proposed work aims
1) to improve the utility, interpretability and quality of single cell embryonic atlases, 2) to leverage whole-
organism approaches to understand developmental regulatory networks, especially the context-specific ability
of the Wnt pathway to regulate lineage-specific targets, and 3) to understand how dynamic processes like high-
rate transcription and RNA turnover control the robust, timely, regulation of developmental decisions. This work
will both extend our understanding of developmental mechanisms, and provide lessons for similar studies in
more complex animals.

Public health relevance
Narrative In animal development the single-celled zygote divides, and its progeny differentiate to produce an incredible diversity of cell types, but we still have much to learn about the molecular changes that occur in cells as they divide and differentiate. This project uses cutting-edge microscopy and genomics tools to study this process in the embryo of the nematode C. elegans, which uses many of the same genes as humans to specify its cell types and allows for rapid experimentation. We will focus on how regulatory genes work in different combinations to allow cells to make different decisions during development, how errors in these decisions are avoided, and how the timing of developmental events is controlled.